PA-22-176, SBIR, Development of a wearable light-based remote monitoring system for early detection of postpartum hemorrhage

PROJECT SUMMARY
There is an urgent need to develop technologies which address preventable causes of maternal deaths and
improve maternal health outcomes. In the United States (US) there exist deeply concerning racial and ethnic
disparities in maternal health outcomes (with black mothers experiencing a >3x higher mortality rate than non-
black mothers). Furthermore, the US has the highest maternal mortality of any high-income country and is one
of only two countries in the world where maternal mortality is rising. This SBIR project is focused on addressing
postpartum hemorrhage (PPH), defined as severe bleeding after delivery, because it is a leading cause of
maternal morbidity and mortality, and >90% of deaths from PPH are considered preventable with early
detection and early treatment. The product of this SBIR project, Maternal aRMOR (remote monitoring optical
reader), will be a wrist-worn sensor and integrated mobile app that obstetric providers use to detect early blood
loss (when inexpensive and accessible treatments like pharmacologic agents and balloon tamponade are most
effective). Maternal aRMOR uses laser speckle imaging to quantify peripheral blood flow. Maternal aRMOR
works by sensing and alerting providers to the changes in blood flow that occur in early hemorrhage when the
body shunts blood to its core to protect vital organs. Unlike visual estimation of blood loss, Maternal aRMOR
provides clinicians with real-time, quantitative information about a patient’s hemodynamic state. Aim 1 of this
Phase I SBIR will evaluate the potential confounding effects of skin pigmentation and motion on aRMOR
signal, to ensure robust and equitable device performance. Aim 2 will establish a subject-specific perfusion
range to improve personalized hemorrhage risk assessment. Aim 3 will demonstrate development of a mobile
app that interfaces between the wearable Maternal aRMOR device and healthcare providers to provide
continuous monitoring for PPH. Phase II of this SBIR project will focus on development of a commercial-grade
device and clinical studies to demonstrate the impact of Maternal aRMOR for improving health and decreasing
healthcare cost associated with PPH. Initial target customers include the >3,200 US-based obstetric hospitals
who serve ~6M patients annually. Ultimately, Maternal aRMOR will set a new clinical standard for early PPH
diagnosis enabling rapid treatments to prevent the devastating complications of delayed hemorrhage
diagnosis, including transfusion, surgery, and death, that currently impact millions of mothers each year.

Public health relevance
PROJECT NARRATIVE In this SBIR, Armor Medical Inc. is developing a wrist-worn point-of-care imaging device that can be used to continuously monitor pregnant patients and alert providers to early signs of postpartum hemorrhage. Postpartum hemorrhage is a global leading cause of maternal death and is 3x more deadly for black mothers in the US compared with non-black mothers, yet more than 90% of these deaths are preventable through early detection and treatment. This research is therefore aimed at helping decrease these unacceptably high rates of maternal mortality by creating an evidence-based, quantitative tool for early hemorrhage detection.